Education and Training

: The Education and Training Unit will address three primary objectives that will serve to encourage inter- and transdisciplinary experience in the context of cancer research. The first objective of this unit is designed to initiate, cultivate, and maintain transdisciplinary experiences for postdoctoral researchers and junior faculty through a placement scheme that exchanges these individuals between participating departments and institutions within the Center. The Unit will also create a graduate seminar course that will be open to all graduate students at Arizona State University (ASU), but be required of graduate students participating in the Center's research. Finally, the Unit will work with Core 1 (the Beyond Center) to facilitate and coordinate a Cancer Forum workshop that emphasizes the transdisciplinary opportunities in Physical Sciences, Biology, and Medicine. This Unit will be integrated with the Dissemination and Outreach Unit in that the graduate seminars and parts ofthe workshop will be video recorded and available on the Center website.

Public health relevance
The Education and Training Unit will improve the education and experience of researchers within the Center and Network in three ways, with an emphasis on creating transdisciplinary approaches to traditional challenges in cancer research. Specifically, the Unit will provide a scientist exchange, graduate course, and assistance with a workshop that emphasizes opportunities in the field. This unit will directly influence and potentially increase the number of people involved in a productive manner regarding the solving of cancer